Time-of -Flight Mass Spectrometer

Time of Flight-Mass Spectrometer (TOFMS) will be a critical instrument facilitating biomedical
research activities in Hampton University (HU) and in the area. In addition, this instrument will
enhance educational outcome in our newly established bachelor's degree in Pharmaceutical
Sciences program.
The TOFMS is an accurate mass platform with capability of providing highest resolution of
molecular mass. The broad application in biomedical research combined with ease-of-use
benchtop nature,TOFMS will significantly facilitate the research in basic, translational, clinical, or
biomedically related behavioral fields. Students and trainees will benefit from access to the
instrument in formal courses. The TOFMS will invigorate current biomedical research,
contribute to the success of HU' long-range biomedical research goals to prepare graduate to
be leaders in biomedical research, to reduce the disparity in the number of individuals from
underrepresented background in biomedical research career, and to enhance research
productivity in the biomedical sciences.
The goals of this program are 1) To enhance educational outcome of students enrolled in our
newly established bachelor' degree of Pharmaceutical Sciences programs, with goals to
address the need of underrepresentation of Pharmaceutical Scientists in the nation. 2) To
enhance the research productivity in biomedical sciences and facilitate the collaboration of
faculty research across the disciplinary in HU campus and in the area. 3) To germinate
innovative ideas and generate preliminary data for increased research proposal submission and
publications.
TOFMS will be housed in a dedicated shared instrument facility to allow open access. A
dedicated laboratory manager, alone with Pl will maintain and operate the equipment. HU is
committed to providing funding necessary to support the post-award operation of the instrument.
An Advisory Committee will be established to formulate a plan and to implement protocol in use,
training personnel and maintenance. In addition, the Advisory Committee will disseminate
information of the instrument availability through the university website to promote broad access
to TOFMS for researchers, students from HU and her area.
In summary, TOFMS will increase research capacities and enhance the new research
opportunities in the region. The student in degree program in Pharmaceutical Sciences and
other biomedical related area will benefit from a hand on research-based education from this
instrument, and that will contribute to our institutional mission in increasing the talent pool from
underrepresented minority on which the U.S. biomedical research enterprise can draw.
Project Summary/Abstract

Public health relevance
The acquisition of Time of Flight -Mass Spectrometer will invigorate biomedical research in Hampton University. In addition, the student in degree program in Pharmaceutical Sciences and other biomedical related area will benefit from a hand on research-based education from this instrument, and that will contribute to our institutional mission in increasing the talent pool from underrepresented minority on which the U.S. biomedical research enterprise can draw. Project Narrative